Regulation of optic stalk development by microglia

PROJECT SUMMARY
Microglia, the resident neuroimmune cells of the CNS, play important developmental roles. During early eye
development, closure of the optic fissure (OF) to form the optic stalk is important for normal vision, since failure
of this process results in coloboma. OF closure depends upon focal apoptosis and remodeling of the basement
membrane, although the mechanisms and cell populations involved are not fully defined. During OF closure we
found that microglia are concentrated in the fissure and appear to be phagocytic. To determine whether
microglia participate in OF closure, the first aim will determine whether microglia eliminate apoptotic cells in the
OF, and determine how this influences microglia remodeling properties. The second aim will test the effect of a
specific microglial recognition pathway required for phagocytic apoptotic cell elimination, and will then test the
effect of microglia depletion on OF closure. This study will shed light on how microglia influence tissue
remodeling in ocular development, and may ultimately inform our understanding of whether microglia
contribute to ocular disease processes such as coloboma resulting in loss of vision.

Public health relevance
PROJECT NARRATIVE: Microglia populate the nervous system early during development, and are present in the developing optic fissure as it is closing to form the optic stalk. This study will investigate whether microglia eliminate apoptotic cells in the optic fissure and whether they facilitate closure, which may yield insight into mechanisms underlying coloboma.